STATISTICAL THERMODYNAMICS OF PROTEINS AND POLYNUCLEOTIDES SYSTEMS

Statistical mechanics was used to derive the binding isotherm for a ligand on a one-dimensional polymer when ligand-ligand interactions extend over an arbitrary number of sites. The main application is to large proteins binding on DNA.